Biotechnology Training Program

PROJECT SUMMARY/ABSTRACT
This proposal requests establishment of a new NIGMS T32 Biotechnology Training Program at
UW-Madison. BTP has an aim of increasing mentoring skills through provision of WISCIENCE-
and NRMN-inspired workshops to our mentors deepen skills and impacts in the promotion of
excellence in science. For our trainees, our aim is to improve their ability to clearly communicate
the basics of science and also to understand the constraints and solutions to carrying out
rigorous, reproducible and responsible research across the breadth of topics relevant to a
successful career in biotechnology. Our training plan focuses on supporting a diversity of
trainees and helping them to learn to speak clearly and interact effectively with a breadth of
colleagues. This is the basis for our cross-disciplinary career development efforts.
Each year, BTP receives up to 100 applications from new TGE students that join our
mentor’s labs. This high level of interest reflects the visible, innovative and successful training
that BTP provides at UW-Madison. BTP requests support for 11 new trainees each year from
this large group of enthusiastic applicants and continued support for a 2nd year, accounting for
our request for a total of 22 NIGMS-funded trainees each year. BTP trainees will receive NIGMS
support during the 2nd and 3rd years of graduate school and participate in BTP program activities
during all years they are in graduate school. BTP trainees (with mentor guidance) will have
leading roles in organizing, teaching and presenting in a completely revamped BTP Seminar,
which provides the framework for our cross-disciplinary approach to integrative training in
rigorous, reproducible and responsible conduct of research. Trainees also complete courses in
responsible conduct of research in the 1st and 4th years, a required course in rigorous and
reproducible methods of research, and an innovative class in entrepreneurship that sets the
stage for internships. BTP trainees will complete internships and other career advancement
opportunities through a newly formed innovative connection to the biotechnology trade
advocacy group BioForward Wisconsin, its ~150 industry members and other sponsors.
BTP is committed to tracking and analyzing the outcomes of its programs, trainees, mentors
and internship sponsors. We will use professionally designed and distributed anonymous
surveys, personal interviews, institutional data and social media to continue this effort and enlist
professionals from the UW-Madison Survey Center and LEAD to carry out independent
assessment and analysis to continually improve the impacts and outcomes of the BTP.

Public health relevance
PROJECT NARRATIVE The University of Wisconsin-Madison Biotechnology Training Program addresses a critical need to educate scientists and engineers in the effective use of cross-disciplinary approaches to solve important problems in biomedical research. This program provides cutting-edge technical, operational and professional training to a diverse cohort of doctoral students drawn from biological, physical and engineering sciences. Ultimately, the career-long contributions of these trainees as leaders in industry, government service and academia are essential to maintain our national excellence and leadership in the application of biotechnology to demanding and dynamic societal needs.